In vivo cell engineering using a bone marrow organoid

PROJECT SUMMARY/ABSTRACT
This project tests a bioinstructive material capable of forming bone and bone marrow in a
localized, easily accessible subcutaneous site as a delivery portal for anti-HIV genetic
engineering constructs. The larger goal is to enable genetic engineering of blood progenitor
and stem cells without requiring hematopoietic stem cell transplantation and without
incurring the liabilities of systemically delivered gene modifying vectors. By enabling easy
access to a subcutaneous bone marrow organoid, small concentrations of gene
engineering vectors can be locally administered reducing the cost of goods and likelihood
of modifying other organs. The organoid will be tuned to produce speciﬁc subsets of cells
appropriate for the varying anti-HIV constructs in Projects 1 and 2. The ability of this
strategy to generate HIV-1 resistant stem and progenitor cells will be tested in humanized
mice and non-human primates in close collaboration with investigators in this project and
the larger program.